Taming Fluorine: Metal-Organic Frameworks for the Heterogeneous Delivery of Fluorinated Building Blocks

Project Summary
Despite decades of reaction development, medicinal chemists still frequently face synthetic barriers when
preparing molecules with potential therapeutic value. For example, the substitution of C–H bonds for C–F bonds
in a target molecule can improve its metabolic stability, membrane permeability, and biological activity, but this
substitution is often impossible to realize in the laboratory. This obstacle arises because the fluorination of
otherwise simple building blocks or reagents generally renders them gaseous, toxic, corrosive, or unstable. While
this “reagent problem” is not limited to organofluorine chemistry, it has prevented significant advances in this
area. Therefore, the overall objective of the proposed research is to “tame” the reactivity of fluorinated building
blocks and enable their use for the construction of complex fluorinated molecules. Specifically, the proposed
multidisciplinary program aims to employ insoluble porous materials, which commonly serve as “hosts” for
“guest” molecules in materials science, to control the reactivity of fluorinating agents. The resulting
heterogeneous species will function as “nanovessels” capable of controllably releasing the stored reagents or
as “nanoreactors” that facilitate new transformations within their pores. The central hypothesis of this proposal
is that metal–organic frameworks, a relatively new class of porous, crystalline materials constructed from organic
“linkers” and inorganic “secondary building units,” are the ideal platform to achieve this objective due to their
unparalleled structural tunability. This research aim is part of the PI’s broader research program to unlock the
potential of metal–organic frameworks for applications in organic synthesis, medicine, and structural biology.
The PI is also exploring the use of electricity as a low-cost tool to enable the synthesis of complex molecules
This administrative supplement will support the purchase of a powder X-ray diffractometer (PXRD) to
facilitate the characterization of MOFs prepared as part of the parent proposal. PXRD is the most important
method for determining the atomic-scale structures of nano-crystalline materials but remains challenging to carry
out at Cornell University. Typically, synchrotron X-ray sources must be used to collect data, which results in
significant delays (>6 weeks) between sample preparation and data acquisition. This purchase would allow for
the acquisition of PXRD data in minutes instead of weeks at Cornell University.

Public health relevance
Project Narrative Fluorine is a ubiquitous element in active pharmaceuticals, but its controlled installation presents a significant challenge due to the volatile reactivity of many fluorinating agents. The parent proposal aims to tackle this challenge by a completely new, multidisciplinary approach that borrows from materials science, namely, to stabilize reactive fluorinated species in porous, sponge-like materials and deliver them on demand. This administrative supplement aims to support this proposal through acquisition of an instrument needed to characterize the atomic structure of synthesized materials.